1/2 CCNY-MSK Partnership for Cancer Research, Education and Community Outreach

The CCNY-MSKCC Partnership has successfully created a mutually beneficial, cross-institutional collaboration that has emphasized research across the translational T0-T4 continuum, the creation of an education pipeline for attracting students to careers in cancer research, and the establishment of community networks and resources for conducting community engaged outreach and research for the next five years. The Partnership focus will be Translational Cancer Research. Consistent with this emphasis, our research projects will focus on: 1) understanding the biological and social factors associated with immune checkpoint inhibitors and evaluating an intervention designed to reduce side effect severity and improve treatment attendance; 2) an examination of small molecule regulation of cancer-driving transcription factors using a interdisciplinary strategy of protein chemistry, chemical, and cellular approaches that could lead to targeted treatments relevant to cancers; 3) the impact of AI integrated, UN-style medical interpreting engineering solutions on cancer care; 4) identification of germline and other factors influencing the tumor genome of lung cancers.

Public health relevance
This proposal describes our plans to continue and expand the City College of New York - Memorial Sloan Kettering Cancer Center Partnership for Cancer Research, Research Education, and Community Outreach, which is a mutually beneficial, cross-institutional collaboration that has promoted translational research, created an education pipeline for students to embrace cancer research careers, and established community networks and resources for conducting community engaged research and education among all populations in the New York area.